The effects of immunosuppression on SARS-CoV-2 persistence, virus genetic diversity and clinical outcomes of COVID-19

ABSTRACT
One of the biggest challenges for the development of Coronavirus Disease 2019 (COVID-19) vaccines and
therapeutics is the emergence of SARS-CoV-2 variants with immune-escape or resistance mutations. Multiple
evidence points to the chronic infection of immunocompromised hosts, especially individuals with hematologic
malignancies, as one of the main mechanisms for the emergence and spread of these variants. While most
people with a competent immune system successfully clear SARS-CoV-2 infection within days, some patients
with hematologic malignancies and weakened immunity get persistently infected for months with virus replicating
often at high titers. As for other RNA viruses, SARS-CoV-2 replication can lead to the rapid accumulation of
mutations over time. Thus, persistent infection of an immunocompromised host provides the timeframe during
which the virus accumulates more genetic mutations than expected from individual infections without the need
of transmission to another host. Moreover, these individuals could remain contagious for longer periods of time
and sustain transmission to the community of variants potentially associated with virus fitness advantages,
including increased transmissibility or resistance to COVID-19 vaccines or treatments. Which host immune
background enables chronic infection, what specific selection acts on the virus, and what effects on the host do
emerging mutations exert over the course of the disease are currently unknown. Moreover, there are no tools
that allow the early identification of subjects that will develop prolonged infection. We hypothesize that specific
defects in B and T cell populations that favor prolonged infection can be leveraged for the development of an
early prediction tool to identify subjects with protracted infection where the virus is accumulating mutations. To
address this, we will integrate patient level and epidemiological data with immune profiling and SARS-CoV-2
deep sequencing to: (1) determine the immune defects linked to prolonged replication or acute disease; (2)
ascertain the effect of different immunosuppressive conditions and therapeutics on SARS-CoV-2 genetic
diversity within the infected host.
Our studies will advance our understanding of the immune mechanisms involved in SARS-CoV2 persistence in
the immunocompromised host and inform the development of optimal therapies and public health interventions
to prevent the emergence and spread of new viral variants. This approach, if successful, is also relevant to other
respiratory viruses.

Public health relevance
PROJECT NARRATIVE. Prolonged infection in immunocompromised subjects with hematological malignancies may play a major role in the emergence and transmission of SARS-CoV-2 variants. We will use a combination of advanced epidemiological, immunological, and molecular methods to determine the effect of host background and treatments on viral persistence and evolution, and the effect on clinical outcome. Information from our study could be used to develop targeted interventions to prevent emergence and spread of treatment-resistant and/or more fit variants.